REGULATION OF LPL IN ADIPOSE AND MUSCLE TISSUE

Lipoprotein lipase (LPL) is decreased in diabetes, and this decrease occurs at the translational level. To study LPL translation in vitro, fat is obtained from controls and diabetics, and cell/molecular studies performed. In 1995, one such specimen was obtained by the GCRC staff prior to the protocol's discontinuation when the PI took a position at another institution.